IGF::OT::IGF "Follow-On 28 Day Dog Pharmacokinetic and Clinical Chemistry Assessments"- SRI International

IGF::OT::IGF Follow-On 28 Day Dog Pharmacokinetic and Clinical Chemistry Assessments- SRI International